Developing a bioprinted ventilated lung alveolar platform for investigating microbial interactions and influenza response

PROJECT SUMMARY / ABSTRACT
Our goal is to understand how the lung microbiome regulates influenza virus infection response by developing a
3D in vitro bioprinted platform to study host-microbiome-influenza interactions in the lung alveolar space. The
respiratory microbiome, encompassing hundreds of different bacterial and fungal species, has essential roles in
the development of tissue-specific immunity and colonization resistance to pathogens, including viral infection.
The lung and alveolar space undergo constant microbial exposure from the inhalation of oropharyngeal contents.
Notably, sequencing-based studies have identified a low biomass but diverse microbial signature in healthy
individuals. However, a detailed mechanistic understanding of how these diverse microbes interact with host
cells to maintain lung health and contribute to viral infection susceptibility is currently lacking. Major knowledge
gaps exist due to 1) the substantial biodiversity of the lung microbiome, 2) difficulties in modeling the complexity
of the human lung environment, and 3) limited information about where in the lung epithelium these interactions
take place and what are the cell-type specific host responses. Additionally, Current approaches lack the capacity
to model host-microbe interactions in the lung at transcriptional and spatial resolution. We will overcome these
limitations by developing two new technologies – a 3D bioprinted alveolar sac model and dual host-microbe
spatial transcriptomics (ST) – to enhance our understanding of the host response to microbial colonization in an
advanced, anatomically relevant lung model. The ability to examine which and how specific microbes interact
with the lung epithelium and the effect these interactions on influenza infection would be valuable to investigate
the microbiome’s role in lung health and infection response. In Aim 1, we will develop and characterize a 3D
bioprinted ventilated alveolar sac model. We will then evaluate its influenza infection response using ST and
single-cell RNA-sequencing. In Aim 2, we will examine how diverse respiratory microbiota condition the alveolar
epithelium to affect influenza infection response. We will develop a dual ST method to simultaneously profile
host transcriptional response and microbial/viral localization. We will then use this method to examine how
microbial conditioning of the epithelium affects influenza infection dynamics. Together, these aims will allow us
to address fundamental questions on the underlying biology of the lung microbiome and its effect on influenza
response. Our success would result in two new technologies facilitating the construction of a high-resolution
spatial map of the microbiome-host interactions. This advancement would enable in-depth investigations into the
mechanisms of interstrain interactions, virulence regulation, and their impact on lung immune homeostasis and
infection response.

Public health relevance
PROJECT NARRATIVE / RELEVANCE TO PUBLIC HEALTH Numerous bacteria, fungi, and viruses inhabit the human respiratory tract and play an essential role in its health and susceptibility to viral infections. We will develop a 3D bioprinted alveolar sac model and approaches to spatially map microbe–alveolar interactions, allowing us to investigate the role of microbes in influenza infection of the respiratory tract.